Role of Perineuronal Nets in Methamphetamine-Induced Hypofrontality and Cognitive Deficits

PROJECT SUMMARY
Hypofrontality corresponds to a state of reduced frontal cortex activity found in several neuropsychiatric
disorders, including substance use disorders and depression, that correlates with cognition and executive
function disabilities. However, the mechanisms underlying hypofrontality development in response to experience
remain unknown. Perineuronal nets (PNNs) are composed of extracellular matrix glycoproteins, are dysregulated
in drug addiction and depression, and have emerged as important regulators of synaptic plasticity in the
developing and mature brain. PNNs formation around parvalbumin-positive fast spiking interneurons (PV+FSIs)
tends to increase PV+FSIs activity, which enhances GABAergic inhibition in neuronal networks and suggests
the potential involvement of PNNs in hypofrontality. Our preliminary data, using a rat model of prefrontal cortex
(PFC) hypofunction (i.e. hypofrontality) induced by chronic methamphetamine (METH) administration, suggest
that chronic METH induces an increase in the percentage of PV+FSIs surrounded by PNNs, associated with an
increase in PV+FSIs excitability, an increase in inhibitory transmission onto pyramidal neurons, as well as the
emergence of cognitive deficits.
The overall objective of this proposal is to study the role of PNNs in METH-induced hypofrontality and cognitive
deficits. The central hypothesis- informed by strong preliminary data and literature- is that METH-induced
increase in PNNs enhances PV+FSIs activity in the PFC and produces hypofrontality and cognitive deficits. Aim
1 will assess when chronic METH self-admnistration initaites changes in PNNs density, expression level and
compostion and whether these changes are long-lasting. Aim 2 will investigate the role of PNNs in METH-
induced cognitive deficits. Aim 3 will assess the role of PNNs in METH-induced hypofrontality.
The proposed research is significant because it will fill fundamental gap in knowledge related to the mechanisms
underlying hypofrontality in METH-addiction. The main conceptual innovation of the proposed study is the
investigation of the link between PNNs and hypofrontality. Furthermore, the knowledge obtained from the
proposed experiments will help to develop effective treatments to ameliorate hypofrontality-related symptoms in
SUD and other psychiatric conditions and can also provide new insights into the basic mechanisms underlying
hypofrontality.

Public health relevance
Narrative: The goal of the proposed studies is to better understand the mechanims underlying hypofrontality development and consequent cognitive defiicts in neuropsychiatric disorders, more specifically in response to drug exposure. Since we found that chronic mephamphetamine (METH) exposure increases perineuronal nets (PNNs) in the prefrontal cortex, known to enhance parvalbumin positive fast spiking interneurons, this study will investigate the role of PNNs in METH-induced hypofrontality. The knowledge generated by this proposal may provide new pharmacotherapeutics targets for multiple disorders with hypofrontality-related symptoms.